Advancing a novel on-demand non-hormonal male contraceptive to IND enablement

PROJECT SUMMARY
With global unintended pregnancy rates at nearly 50%, and even higher rates among adolescents in the United
States, there is a profound unmet need for reliable and convenient to use contraceptive options. While multiple
contraceptive alternatives exist for women, condoms, with a 13% yearly average failure rate, and surgical
vasectomy are the sole contraceptive options available to men. The global contraceptive market was $22.5 billion
in 2021 and is expected to grow to over $31 billion by 2026. Recent multi-country market research indicates that
over half of all men of reproductive age would try a new male contraceptive, with a new contraceptive option for
men likely to grow this market considerably as well as have the greatest impact towards reducing unintended
pregnancies. In the United States, men favor an on-demand, nonhormonal, orally available option. To meet this
demand, Sacyl Pharmaceuticals, Inc (SACYL) is developing small molecules that will provide innovative first-in-
class, nonhormonal, reversible, pre-coital, on-demand contraception for men via inhibition of soluble adenylyl
cyclase (ADCY10; sAC) in sperm. sAC is genetically and pharmacologically validated as a target for male
contraception in both mice and men. SACYL has licensed the exclusive worldwide rights for systemic delivery of
a series of drug-like sAC inhibitors, which impede progressive motility of human and mouse sperm and
demonstrated 100% contraceptive efficacy in preclinical mouse mating studies. In this phase 1 SBIR application,
we request funding to advance our sAC inhibitor leads towards preclinical development. On-demand male
contraception is a novel concept which (to our knowledge) has never been evaluated by the FDA; therefore, in
Aim 1, we will develop the new strategy needed to hold an initial meeting with the FDA to progress our
advanced candidates to an Investigational New Drug (IND). Because the sAC inhibitor used to successfully
demonstrate proof-of-concept for on-demand contraception in male mice still has liabilities which limit its utility
as a clinical asset, we have developed a series of advanced leads with improved efficacy-defining features. In
Aim 2, we will assess metabolic stability and oral bioavailability to identify the lead and backup preclinical
compounds to advance into IND enablement. Upon completion of this phase 1 award, we will present a clinical
lead (and backup) compound and a development strategy to the FDA in a pre-IND meeting.

Public health relevance
PROJECT NARRATIVE Global unintended pregnancy rates remain close to 50%, indicating a significant unmet need for individuals wishing to control their reproductive autonomy. All but two of the modern contraceptive methods available are female-controlled (i.e., condoms and vasectomy), and recent market research reveals men are eager to try a new option, especially a user-controlled on-demand oral contraceptive. To address this demand, Sacyl Pharmaceuticals is developing a revolutionary, first-in-class, on-demand, nonhormonal, small molecule male contraceptive that disrupts sperm's fertilizing ability for men to take only when, and as often as, needed.